Single-cell Analysis of Primary Effusion Lymphoma Patient-Derived Xenografts from HIV-AIDS Patients to Identify Molecular Targets for Intervention

We are scheduled to perform single cell RNA sequencing in upcoming weeks on sixteen samples that will encompass the six PEL-PDX samples, before and after expansion in NSG mice, and before and after flow sorting for purity. We are applying a library preparation and sequencing methodology that will enable us to capture viral and host transcripts, to better examine the heterogeneity of these lymphoma cell lines, within and between patients. We have a bioinformatic pipeline in place to define the gammaherpesvirus and host transcriptional program and altered host networks that we expect will aid in the identification of candidate biomarkers and novel therapeutic targets.